Principal Project: B cell response underlying Celiac disease antibody and autoantibody responses

PROJECT SUMMARY
Celiac disease (CD) is an immune mediated disorder in which there is an immune response to the exogenous
antigen gluten (from wheat, rye, and barley) in individuals who are HLA restricted. The disease causes
duodenal inflammation but can be reversed by withdrawal from gluten. Patients experience loss of oral
tolerance (LOT) to gluten, with T cells and B cells reactive. Patients also produce mucosal autoantibodies to
the enzyme transglutaminase 2 (TG2) which is involved in gluten metabolism. We previously found that TG2-
specific plasma represent 10% of antibody-secreting cells (ASCs) within the duodenal mucosa of patients with
active CD. These anti-TG2 B cells and antibodies are believed to enhance or perpetuate disease either directly
through antibody-mediated effector mechanisms, such as compliment deposition, or by presentation of gluten
peptides, perpetuating the LOT by T cells. It is therefore important to understand the origin of anti-TG2
autoantibody responses. We also previously found that anti-TG2 antibodies were encoded by a highly
restricted repertoire of Ig genes, consisting predominantly of VH5-51 and two other VH genes. Repertoire
restrictions such as this are often reminiscent of a distinct subset of B cells, predominantly expressing Ig
encoded by VH5-51. We now have preliminary data identifying a recirculating subset of IgA+ B cells that
exhibit the same repertoire restrictions as the anti-TG2 antibodies but found in the blood of all healthy subjects.
Notably, the recirculating population of IgA+ B cells and antibody-secreting cells (ASCs) in particular, has been
associated with microbiota interactions. We hypothesize that these cells represent a distinct functional subset
of the IgA peripheral blood repertoire that normally provides mucosal protection, but that can be induced to
secrete anti-TG2 autoantibodies in susceptible individuals upon gluten exposure. In aim 1 we will characterize
the functional phenotype and transcriptome of this subset and we will determine if the subset is clonally linked
to anti-TG2 mucosal ASCs in patients. In aim 2 we will characterize the microbiota specificity of these blood-
borne IgA ASCs from the blood and biopsied mucosal ASCs from patients with active disease and from control
subjects at the monoclonal level. Finally, in aim 3 we will explore the origin of the TG2 autoantibody response
in mucosal tissues. Particular cellular functions or distinct targeting of particular microbes, plus differences from
control subject cells could provide important insight into the etiology of celiac disease. A novel cell-surface
phenotype, such as expression of a particular CD marker, for example, or a particular cytokine receptor, could
provide distinct targets useful for therapeutic intervention into disease.